Democratizing embryo biomechanics: Development of robust and accessible methods to quantify sub-cellular mechanics in vivo

Abstract:
It is now widely recognized that any comprehensive understanding of morphogenesis will
require careful quantification of mechanical forces in vivo. However, twin challenges stand in our
way: First, we currently possess only a sparse sampling of subcellular mechanics in embryos, in
part because such analyses are limited by the need for advanced instrumentation. Second,
most analyses of mechanical properties do not provide sufficient spatial resolution to quantify
localized mechanical heterogeneities in discrete sub-regions of the cell. Here, we attack both
problems by developing robust methods for non-invasive quantification of the mechanical
properties of both cell-cell junctions and the cytoplasm. The proposal will develop these tools in
the context of vertebrate embryo axis elongation, but both methods should be widely accessible,
requiring only fluorescent reporters and standard microscopes. Success of the project would 1)
improve our depth of understanding through their high spatial and time resolution and their non-
invasive nature and 2) improve our breadth of understanding by making quantitative
biomechanical analysis in embryos far more accessible to a wide range of investigators.

Public health relevance
Narrative: Convergent extension (CE) is an evolutionarily conserved collective cell movement that elongates tissues and organs and is fundamentally required for normal embryonic development in diverse animals, including mammals. Defects in CE are associated with birth defects in humans. In this proposal, we will combine quantitative cell biology with concepts from mechanical engineering and physics to understand cells generate the directional forces required for cell movement during CE.